Statistical methods for genomic analysis of heterogeneous tumors

Project Summary
In most cancers, heterogeneous cell composition within and between tumor samples is mirrored in complex
variations at a molecular level. This molecular complexity includes both transcriptional variation and genomic
complexity, since tumors continually evolve and acquire new mutations. Therefore, to further our understanding
of tumor evolution, it is essential to study the evolutionary dynamics between cancer genomes and
transcriptomes. However, due to the complex interplay between cancer cells and their environment, these
dynamics are still poorly understood, which presents a major bottleneck for the advancement of clinical
management and treatment of cancer patients. Recent multi-region matched DNA/RNA sequencing studies have
made significant advances in our understanding of cancer evolutionary dynamics. However, the analytical tools
used in these studies were limited to one molecular data type at a time, representing a missed opportunity for
novel biological discovery. The overall objective of this proposal is to 1) quantify, at scale, the evolutionary
dynamics between genomic and transcriptomic variations in cancer cells; and 2) link this quantity to cancer
prognosis and therapeutic response. On the methodological side, we will develop a suite of integrative
deconvolution models for matched genomic and transcriptomic data types. Multiple angles to approach the
matched data will be evaluated in separate statistical models. On the applied side, we will focus on the clinical
impact of such models on the treatment of prostate (PCa) and thyroid cancers (THCa). These two cancers rank
3rd and 12th in prevalence and are projected by the CDC to present a total of 292,810 new cases in 2021 in the
US. For both cancers, overtreatment is the most clinically urgent problem since there is no clear method to
differentiate low-risk patients from those at high risk. We hypothesize that biomarkers informed by tumor
evolutionary trajectory may identify patients who do not need further treatment. Identification of these biomarkers
would significantly improve the efficiency of clinical practice. Our research group consists of experienced
investigators with complementary expertise in tumor heterogeneity and clinical management of cancers.
Together, we propose the following Aims: 1. Develop integrative deconvolution models to study the evolution of
transcriptomes in cancer cells, 1A) at the cell-type and gene levels, 1B) at single-nucleotide-variant level, 1C)
genomic heterogeneity over a multi-sample design, and 1D) transcriptomic heterogeneity over a multi-sample
design; 2. Apply integrative models to cancer patients for biomarker discovery in 2A) high-risk prostate cancer
and 2B) high-risk thyroid cancer; 3. Develop user-friendly and computationally efficient software tools for cancer
genomics. The proposed methods and tools are expected to open new avenues to discovery by enabling
comprehensive profiling of tumor cell types over evolution and associating these values with clinical outcomes.
Our proof-of-principle investigation of prostate and thyroid cancers has the potential to identify new integrative
biomarkers predictive of cancer prognosis and response to treatment.

Public health relevance
Project Narrative The proposed research is relevant to public health because it will provide analytical tools for a deeper dissection of tumor heterogeneity and a comprehensive reanalysis of the vast amounts of sequencing data from large public databases or research clinics. It will also offer new opportunities to understand the plasticity of tumor cells and its relationship with cancer clinical outcomes.